Web-based Pain Coping Skills Training to Improve Pain and Poor Adherence caused by Aromatase Inhibitor-Associated Arthralgia In Breast Cancer Survivors (SKIP-Arthralgia): A Randomized Controlled Trial

Aromatase inhibitors (AIs) are standard post-treatment care for postmenopausal breast cancer survivors (BCS)
with hormone-receptor positive (HR+) tumors. AIs improve survival and reduce risk for cancer recurrence, but
they also cause significant adverse effects. The most common is arthralgia—joint pain and stiffness that affects
about 50% of BCS beginning soon after starting an AI. Painful arthralgia causes emotional distress and poor
health-related quality of life (HRQoL). It is also the AI side effect most strongly linked to AI adherence problems,
which are a critical medical concern. Current medical and behavioral interventions for managing painful arthralgia
help only a minority of BCS, cause toxicities that limit their use, or have weak evidence, revealing a critical gap
limiting ability to reduce the impact of painful arthralgia on BCS using AIs. We propose to fill this critical gap with
Pain Coping Skills Training (PCST), a cognitive-behavioral therapy (CBT)-informed intervention. To our
knowledge, no study has evaluated PCST for management of AI-associated painful arthralgia, although
randomized controlled trials (RCTs) show that PCST and similar interventions delivered by trained therapists
can improve pain and reduce disability in people with cancer, chronic musculoskeletal pain, and other pain
conditions. Despite efficacy, PCST continues to be underused in clinical care due to barriers such as high
resource costs, lack of availability in some geographic areas, travel requirements for patients, and a shortage of
trained therapists. We developed a web-based PCST program called painTRAINER to overcome these barriers,
using a novel approach to optimize engagement and retain therapeutically critical features of therapist-delivered
PCST in an “automated” program that does not require therapist involvement. PainTRAINER mimics highly
interactive and personalized therapist-delivered PCST. RCT evidence shows that painTRAINER is highly
acceptable and engaging, and that it can reduce joint pain and stiffness in people with osteoarthritis (OA). We
now seek to evaluate whether it can improve the severity of painful arthralgia and its associated interference and
other adverse impacts on BCS on AI therapy. The proposed multi-site RCT will randomize 452 BCS with AI-
associated painful arthralgia to enhanced usual care (EUC) or painTRAINER+EUC. Assessments will occur at
baseline, post-intervention (12 weeks after baseline), and 3- and 6-months post-intervention. Aims are to
determine whether painTRAINER+EUC, compared to EUC, improves pain severity and pain interference (Aim
1, primary outcomes) as well as distress, HRQoL, and AI adherence (Aim 2, secondary outcomes). We will also
determine whether these effects on primary and secondary outcomes are at least partially mediated by increases
in pain self-efficacy and reductions in pain catastrophizing (Aim 3). Finally, for an exploratory aim we will evaluate
beneficial indirect effects on sleep problems and vasomotor symptoms in addition to gathering participant
feedback on painTRAINER’s fit for their unique needs. This RCT could yield a highly disseminable intervention
that could be quickly implemented clinically, including in geographic areas with limited access to PCST.

Public health relevance
Aromatase inhibitors (AIs) reduce cancer recurrence and improve survival in breast cancer survivors who are postmenopausal and have hormone-receptor positive (HR+) tumors, but they also cause painful arthralgia that is distressing, reduces health-related quality of life, and contributes to poor AI adherence. Pain coping skills training—an evidence-based cognitive-behavioral pain intervention—could address these problems, especially if delivered as an automated, web-based program that overcomes current barriers to accessing it. Expanding access to an evidence-based behavioral pain intervention that is low cost and highly scalable is consistent with guidelines for managing pain in cancer and would be a step towards addressing symptoms limiting health and well-being in breast cancer survivors on AI therapy.